Translational Research: Host-Pathogen Interactions in Patient Fungal Diseases

1) Improving treatment of cryptococcal meningitis. Cryptococcus neoformans is the most common cause of non-viral meningitis in the U.S. and the disease continues to have an attributable mortality of approximately 30% despite therapy. We have recruited approximately 160 patients with both meningoencephalitis and pulmonary disease. The protocol utilizes the latest in immunological and genetic methods and is divided in two parts: 1) to characterize and apply novel therapeutics to the acute phase of the disease to improve outcomes and 2) identify genetic and immunological risk factors involved in susceptibility to the disease during the convalescence phase.
1) Previously, we reported 15 patients treated with pulse corticosteroid-taper (PCT) therapy that has resulted in reducing the mortality approximately 10-fold to less than 2%. We have also employed this therapy in a new report of PIIRS in a patient with Histoplasma meningitis as well as patients with solid organ transplants and a patient with a CD40L deficiency. We have now completed treatment recommendations for the management of non-HIV cryptococcal disease from multiple centers and includes previously healthy as well as transplant patient recommendations. We have also completed several key case reports that describe unique aspects about cases that could be instructive. We have also completed a multi-center study of non-HIV cryptococcal disease in 20 centers across the United States and have described key neuroimaging results that could improve the monitoring and therapy of these patients. We have also collaborated with David Meya and David Boulware to design and execute a phase II study of an oral nanocrystal amphotericin preparation based on our preclinical work.
2) Host susceptibility to cryptococcal disease in previously healthy individuals. a) Autoantibody to host cytokines: Previously, in collaboration with S. Browne of LCID, we had identified patients with C. gattii, a related form of Cryptococcus with an autoantibody to the macrophage stimulator granulocyte-monocyte stimulating factor, GM-CSF. We are presently studying the regulatory pathway of GM-CSF signaling and have found that autophagy plays a key role in concert with the macrophage inflammasome pathway, suggesting novel mechanisms for intervention.
b) Genetic Defects: We have currently performed whole exome sequencing on 120 patients with CM disease and have identified the lipid metabolism pathway to be predominantly affected in these patients as well as a number of other mutations in the inflammasome and miRNA-regulatory circuits that are under active investigation.